GASLESS LAPAROSCOPY VS. LAPAROSCOPY WITH CO2 PNEUMOPERITONEUM

The purpose of this study is to compare the use of gasless laparoscopy in bilateral tubal cauterization with the same laparoscopic procedure performed in the more conventional manner using a CO2 pneumoperitoneum.